2023 Epithelial Differentiation and Keratinization GRC & GRS

Project Summary
The 2023 Gordon Research Conference on Epithelial Differentiation and Keratinization (GRC-EDK) is
the premier international meeting in epithelial biology, evidenced by the regular attendance of international
leaders in this field, the size of its applicant pool and the overwhelmingly positive attendee reviews. The GRC-
EDK has been held bi-annually since 1979 and showcases the latest conceptual and technological advances
in epithelial biology which have consistently moved the field forward with direct impact on human health. To
maintain the pre-eminent quality of past meetings, this meeting in 2023 entitled “Novel mechanisms of
regulation in epithelial biology and their implication in physiology, aging and disease” aims to bring
together preeminent speakers at the forefront of stem cell biology, cancer, regenerative medicine, immunity,
aging, epigenetics, skin diseases, novel single cell molecular technologies, global genomics, and novel
therapies. The objectives and long-term plans of this conference is to present and discuss the latest
developments in these different fields of expertise through both formal and informal discussion as well as
generate new opportunities of synergestic team approaches towards future discoveries and novel therapeutic
prospects to advance the field as a whole. The excellence of the science is rooted into the diversity with
respect to topic, location and gender. Over 20% of speakers are from outside the immediate field, 85% did not
speak in the 2019 meeting, and over 30% of oral presentations will be selected from submitted abstracts to
accommodate late breaking exciting stories and ensure plentiful speaking opportunities for early career
investigators and trainees. The relatively isolated location and residential nature of the 2023 Conference, and
the informal afternoon periods, maximize opportunities for scientific discussions, mentoring interactions and
new collaborations. Finally, a power hour on the first day of the conference will catalyze important discussions
for ways to recognize and tackle discriminations in science. For 2023, we will continue our commitment to
trainee mentorship through the 5th Gordon Research Seminar on Epithelial Differentiation and
Keratinization (GRS-EDK), immediately preceding the GRC-EDK. GRS meetings are organized and featured
by trainee scientists providing a unique opportunity to not only discuss their science in an informal supportive
setting but also to network with peers and develop life-long collaborations. The GRS-EDK will also feature a
career mentoring panel discussion with special emphases on transitioning to career independence, careers in
academia versus industry, and the importance of gender and racial diversity within science. Collectively, these
programs reflect the vision of NIAMS institute executed through three fundamental areas 1) moving forward
cutting edge research in the area of skin biology; 2) promoting translation of key research findings to clinical
practice, and 3) furthering the careers of early stage investigators and trainees to maintain the highest level of
innovation of this field.

Public health relevance
Narrative The biannual Gordon Research Conference on Epithelial Differentiation and Keratinization (GRC-EDK) has been held since 1979 and highlights the latest conceptual and technological advances that address basic problems in epithelial biology and, importantly, translates these discoveries to treat human disease. Following in this tradition, the 2023 GRC-EDK and its associated, trainee-run Gordon Research Seminar (GRS), will focus on immunity, tissue sensing and cross-talk, genomics and epigenomics, and novel technologies to drive therapy. These meetings will showcase the latest cutting-edge findings in stem cell biology, cancer, regenerative medicine, immunity, aging, epigenetics, skin diseases, novel single cell molecular technologies, global genomics, and promote clinical advances.